A CRISP(e)R way to silence HIV

PROJECT SUMMARY:
In aging HIV-infected populations comorbid diseases are important determinants of morbidity and mortality.
HIV patients die of non-AIDS comorbidities almost a decade earlier that their non-HIV counterparts. cART is
unable to eradicate HIV due to established HIV reservoirs. Mounting evidence suggests that exhaustion of the
latent viral reservoirs leads to either a complete cure (sterilizing cure) or a remission (functional cure). HIV
establishes reservoirs at several anatomical sites like peripheral blood, CNS, lung, etc. Gene therapy has shown
enormous promise but its application towards HIV cure is limited due to limitations like viral escape, off-target
effects and most importantly delivery and bioavailability to infected cells.
Gene editing using CRISPR/Cas9 has tremendous potential in HIV gene therapy and reports have shown
excision of HIV from infected cells. However, CRISPR based HIV excision is vulnerable to viral escape as well
as off-target effects. P-TEFb, a heterodimer of cyclinT1 and CDK9 is recruited by HIV Tat and plays a pivotal
role in releasing the elongation block to allow transcription to proceed from the HIV LTR. Interaction of Tat with
CyclinT1 is critical to recruit PTEF-b to turn ON HIV transcription, while CyclinT1 can be substituted by other
cyclins for cellular transcription. This criticality for HIV transcription and redundancy for cellular transcription
makes CyclinT1 an ideal cellular factor to block HIV with minimal effects on cellular transcription. Inhibition of
Cyclin T1 has been shown to completely inhibit HIV transcription. Hence a CRISPR mediated inactivation of
CyclinT1 will completely block HIV transcription, locking it in an inactive form in the cell thereby effecting a
functional cure. Effecting CRISPR-mediated CyclinT1 knockdown only in HIV infected cells provides an
additional insulation from any toxicity or off-target effects. We will restrict CyclinT1 knockdown only in infected
cells by co-expressing gRNA targeting Cyclin T1 along with Cas9 from a Pol II mono-promoter based single
transcription cassette using our patented LTR-hsp fusion promoter co-expression cassette. Expression is self-
limiting as the co-expression cassette is also dependent on HIV Tat-CyclinT1 interaction thereby preventing
generation of adaptive immune responses. Upon CyclinT1 knockdown, expression of gRNA and Cas9 will cease
from the fusion promoter. We will combine this specific expression with lentiviral vector based in vivo delivery
using a regimen that has demonstrated delivery and transduction of bone marrow stem cells and PBMCs. In Aim
1, will determine the efficacy of our self-limiting HIV inducible gRNA-Cas9 co-expression cassette to block and
lock HIV proviral transcription in primary cell models of infection and HIV latency. Aim2 we will test the
pharmacokinetics, toxicity and efficacy of lentiviral vector based in vivo delivery of our HIV inducible CRISPR
targeting CyclinT1 in small animal models of HIV infection and latency. This application responds to key
objectives of RFA-AI-20-076 by proposing “in vivo gene therapeutic strategies with selective regulation of genetic
payload expression to maximize on-target efficacy and minimize off-target effects.”

Public health relevance
PROJECT NARRATIVE: Non-AIDS comorbidities are a significant cause of mortality in people living with HIV in the cART eRA due to the inability to erradicate HIV reservoirs in diverse anatomical sites. Gene therapy approaches directly targeting HIV are largely ineffectual due to escape mutants and a lack of an in vivo delivery mechanisms for transgenes. Combining broad spectrum in vivo delivery of CRISPR-based approaches with selective and self-limiting expression only in HIV-infected cells can overcome these limitations.